Data Management and Analysis Core

The Data Management and Analysis Core (DSC) will be responsible for performing and supporting
biostatistical analyses and management of multidimensional and subject metadata sets generated in the OmiT-
HIV program. A custom project will be created and maintained on the UCSF Data Library platform to store,
secure, curate, and make accessible all raw and processed biological data and de-identified clinical data
associated with the research program. We will interface with each project team for data ingestion and provide
statistical and bioinformatic support to each. We will additionally perform multi-modal integrative analyses,
including cross-species analysis, to answer questions within and across each project toward better
understanding how vaccine regimens and metabolic conditions influence T-cell responses to and virologic
outcomes of therapeutic vaccination.
We will accomplish these goals with the following specific aims:
Aim 1: Develop and maintain a centralized system of data management and sharing using the UCSF
Data Library.
- We will leverage the UCSF Data Library (UCDL) to facilitate the ingestion, curation, and secure storage
of the diverse high-dimensional data types and metadata or de-identified clinical data generated across
the projects.
- We will apply shared data schemas per modality that store raw and processed data and annotations.
- The UCDL supports web-based data sharing across all members of project and core teams as well as
serves as a staging area for the transfer of all raw and processed data and metadata to ImmPort and
other public databases.
Aim 2: Provide statistical analysis and bioinformatic support for testing project hypotheses relevant to
vaccine regimens, T-cell features, metabolomics, and rebound kinetics.
- We will apply standardized and custom approaches to harmonize datasets for use by all teams.
- We will work collaboratively with each project and core team to perform described analyses including
dimensionality reduction, differential analysis, and association with outcomes.
Aim 3: Integrate multi-modal data to develop a model of joint immune and metabolomic influence over
vaccine responses and control over viremia in ATI.
- We will leverage the complementary nature of these projects and state-of-the-art integrative analysis
techniques, including cross-species analysis, to construct models relating multi-modal factors to
longitudinal immune and virologic outcomes.
- We will address the Bridging Hypotheses described in the Overall component.

Public health relevance
The Data Management and Analysis Core (DSC) will be part of a project to better understand and improve immune responses to therapeutic vaccines. We will perform and support the statistical analyses that allow meaningful conclusions to be drawn that can improve human health.